SEARCH-CKD: The nature of chronic kidney disease and elevated blood pressure in sub-Saharan Africa.

PROJECT SUMMARY/ABSTRACT: Through this K23 award, Dr. Anthony Muiru will obtain the knowledge,
skills, and expertise necessary to become a leading investigator in patient-oriented clinical research of chronic
kidney disease (CKD) and elevated blood pressure (BP) among people of recent African ancestry. During his
renal fellowship, he leveraged the infrastructure of the Sustainable East Africa Research in Community Health
(SEARCH) study to define the epidemiology of CKD in rural East Africa. He established the SEARCH-CKD
study, comprising a representative sample of 3,686 SEARCH participants from rural Uganda and Kenya. Key
findings from initial work in SEARCH-CKD included: 1) High prevalence of unexplained leukocyturia and
hematuria; 2) a striking geographic variation in CKD prevalence; and 3) high prevalence of elevated BP among
individuals with CKD. Dr. Muiru intends to follow up on these initial SEARCH-CKD findings to achieve the
following goals: 1) transform SEARCH-CKD from a cross-sectional study into a longitudinal cohort study; 2)
gain hands-on experience in longitudinal cohort management, collection of bio-samples and subsequent
measurement of analytes; 3) acquire expertise in advanced epidemiological and biostatistical methods,
environmental epidemiology; and 4) obtain certification as a hypertension specialist. To achieve these goals,
Dr. Muiru has assembled a multidisciplinary team of mentors and advisors, he will enroll in a customized
selection of courses, and will continue to leverage the infrastructure established by the SEARCH study.
CKD leads to elevated BP and elevated BP in turn accelerates CKD progression. The burden of these two
conditions is growing dramatically in sub-Saharan Africa. This K23 award will allow Dr. Muiru to address key
knowledge gaps in regard to CKD and elevated BP in rural East Africa and provide him with the support and
mentorship necessary to accomplish the following aims: 1) determine the significance of leukocyturia and
hematuria observed among individuals living in rural East Africa; 2) examine potential risk factors for CKD that
may explain the geographic variation in CKD prevalence in rural East Africa, 3) define BP phenotypes among
participants with CKD (~half HIV-positive) by obtaining standardized single time-point BP measurement
followed by 24-hr ambulatory blood pressure measurement. This proposal will provide Dr. Muiru with an
invaluable training platform that will propel him into an independent research career. In addition, the proposed
research will advance our understanding of kidney disease and elevated BP among people of recent African
ancestry.

Public health relevance
Project Narrative: Chronic kidney disease (CKD) leads to elevated blood pressure (BP) and elevated BP in turn accelerates CKD progression. Scientific knowledge gained from the study of CKD and elevated BP in sub- Saharan African can inform the development of health care policy to address the burden of these conditions in this region and generate valuable insights regarding disease pathogenesis in people with recent African ancestry who carry a disproportionate burden disease around the world, including in the US.